Core C: Translational and Transformative Research

PROJECT SUMMARY
Nationally, drug overdose is the leading cause of adult accidental death, claiming more lives every year than
every armed conflict since the end of the World Wars. Rhode Island is a state devastated by overdose
mortality and morbidity. The enormity and urgency of the opioid crisis call for new, translational approaches
and faster dissemination of research and promising interventions to transform the care of opioid addiction and
overdose, in Rhode Island and nationwide. To maximize the impacts of such scientific findings on the
behaviors of patients, clinicians, healthcare systems, and policy makers, the COBRE on Opioids and Overdose
needs concerted efforts and key resources to both generate and execute translational research and to create
effective study dissemination tools. Local resources to encourage and nurture translational research in the
social and behavioral to clinical sciences are limited, and opportunities for skill acquisition, concept
development, simulation, and user testing in translational research are not sustained over time. To better
optimize the efficacy and reach of the proposed projects, resources to generate and execute translational
research and to create effective study dissemination tools are needed. The Translational and Transformative
Research (T2) Core aims to continue to provide expert support and technical assistance to junior investigators
and affiliated researchers at Rhode Island Hospital, Brown University, and other area hospitals and academic
institutions. The long-term goal of the T2 Core is to establish a regional and national hub of translational and
transformative resources capable of supporting junior investigators, COBRE projects, and the broader scientific
community as they bridge theory to promising intervention and research to practice and policy change for
opioid use disorder and overdose. The Core aims are to: 1) Support the execution of high-quality, impactful
translational and implementation COBRE-affiliated studies through expert consultation and data collection
support on qualitative research, translating theory into intervention, laboratory testing supports, and
technology-driven interventions; 2) Develop a culture of excellence and innovation in translational and
transformative training and research on opioid use and overdose by hosting annual meetings and contests and
quarterly workshops and trainings; and 3) Promote and support implementation and dissemination of COBRE-
affiliated research study findings by assisting with data presentation, plans for dissemination, and study
communications, including to vulnerable populations and affected communities. Led by experienced and highly
productive researchers with extensive mentoring experience, the T2 Core will inspire innovation in translational
and transformative research and provide a valuable resource for the COBRE studies.